The Dynamics of Health, Aging and Body Composition (Health ABC) Research Study

The major objectives of the HEALTH ABC Study relate to observations that change in body composition in old age, particularly the increase in body fat and the decline in lean mass and bone mineral, represent a common pathway by which multiple diseases contribute to disability.